Microphysiological systems to Advance Precision medicine for Alzheimer's Disease and Related Dementias (MAP-AD)

PROJECT ABSTRACT/SUMMARY IU MAP-AD Overall Abstract/Summary
The Indiana University Microphysiological systems to Advance Precision medicine for AD/ADRD (IUMAP-AD)
Center is committed to establishing a multi-component Alzheimer’s disease and Alzheimer’s disease related
dementias (AD/ADRD) Translational Center for Microphysiological Systems (MPS). AD is a leading cause of
dementia worldwide, with current estimates of nearly 6 million Americans currently affected by the disease. AD
is associated with many accompanying pathologies including inflammation and activation of microglia and
astrocytes, dysfunction of vasculature, as well as synaptic and eventual neuronal loss. Additionally, recent
studies have identified numerous genetic risk factors associated with AD/ADRD at loci with known functions in
glial and vascular cell types. However, our understanding of how these genetic risk factors and cell types
contribute to AD/ADRD pathology remains somewhat limited, especially in the human system. Thus, to overcome
these shortcomings, we propose to build on our extensive knowledge and tools acquired from the ongoing
MODEL-AD, TREAT-AD, and CLEAR-AD consortia at Indiana University, as well as our extensive expertise in
induced pluripotent stem cell (iPSC)/organoids, intelligent systems, and AD/ADRD research across the
University. Our overarching goal is to develop reproducible, scalable, and standardized 3D brain organoid-based
MPS models that recapitulate key features of human AD/ADRD pathophysiology. In the process, we will also
generate numerous resources for investigation among the research community which will be readily shared,
including novel cell lines, protocols for the development and implementation of MPS models, and datasets
derived from the use of MPS models. These models will thus serve as precision medicine research tools to
investigate the complex biology of AD/ADRD and accelerate multiple aspects of drug discovery and preclinical
drug development.

Public health relevance
NARRATIVE IU MAP-AD Center The Indiana University Microphysiological systems to Advance Precision medicine for AD/ADRD (IU MAP-AD) Center is committed to establishing a multi-component Alzheimer’s Disease (AD) and AD-Related Dementias (ADRD) Translational Center for Microphysiological Systems (MPS). The overall goal of this proposed Center is to develop human induced pluripotent stem cell (iPSC)-based 3D models as reproducible and scalable platforms for the more effective study of Alzheimer’s disease and Alzheimer’s disease related dementias (AD/ADRD) pathophysiology. These models will serve as precision medicine research tools to investigate the complex biology of AD/ADRD and accelerate multiple aspects of drug discovery and preclinical drug development, as well as provide a robust and reproducible set of tools, datasets, and resources for the scientific community.